SOT Annual Meetings

PAR−19−306 FDA Scientific Conference Grant Program (13/U13)
Project Abstract/Summary:
The Society of Toxicology (SOT) Annual Meeting and Expo is the largest toxicology
meeting and exhibition in the world attracting more than 6,000 scientists from industry,
academia, and government from more than 50 countries around the globe. The 59th
SOT Annual Meeting will be held at the Anaheim Convention Center (fully compliant
with the accessibility guidelines of the Americans with Disability Act) in Anaheim,
California, from March 15−19, 2020. The annual meeting program includes plenary and
other featured sessions, as well as more than 60 Scientific Sessions, 2,000 abstracts,
and 14 Continuing Education (CE) courses. In addition to the CE courses and scientific
sessions, five informational and two education-career development sessions
demonstrate the commitment of SOT to life-long learning and intellectual scientific
stimulation.
The 2020 scientific program is designed to maximize exposure to ground-breaking
research and opportunities for networking and professional development. To promote
and encourage scientific engagement with scientists from around the globe, there are
several featured sessions to highlight these collaborations.
Furthermore, SOT attendees can take advantage of the ToxExpo offering
comprehensive product information and cutting‒edge technology from more than 300
companies. There also will be a multi−day Undergraduate Diversity Program for
undergraduates and their mentors who are underrepresented in the sciences to
encourage and help prepare the next generation of scientists.

Public health relevance
PAR-19-306 US FDA Scientific Conference Grant Program (R13/U13) Project Narrative: The SOT Annual Meeting provides the most complete and in-depth coverage of toxicology. The SOT Scientific Program Committee is charged with creating a thought provoking and dynamic program that captures all the latest scientific advances that have occurred during the past 12 months. The committee reviews more than 2,000 abstracts to develop a final program that is novel, multi- dimensional, and comprehensive in scope.